Protein Misfolding Diseases and Oxido-Reductive Pathways

DESCRIPTION Abstract Certain inherited modes of heart failure and several neurodegenerative diseases are characterized by protein misfolding states whose underlying mechanism(s) and pathophysiology are poorly understood. Effective therapies exist primarily as goals, not as clinical implementations. Macromolecular damage induced by oxidative stress is the sine qua non for thinking about many diseases. Our laboratory has challenged this paradigm by demonstrating that mouse hearts exhibiting protein-folding cardiomyopathy found in humans are under 'reductive stress'from an over-active antioxidative system. Decreasing the function of glucose-6-phosphate dehydrogenase (G6PD), which generates the reductant NADPH, "cures" the disease in mice by ameliorating reductive stress, aggresome formation, hypertrophy, heart failure and death. This experiment defines a novel causal mechanism and implicates G6PD as a potential therapeutic target. We hypothesize that stress response and anti-oxidative pathways undergo a pathogenic transition, and become dysregulated by macromolecular stresses (e.g., misfolded proteins). We further propose that other cardiac and neurodegenerative diseases result from similar pathogenic transition. Our Pioneer Award proposal is designed to develop a robust experimental platform for exploring the mechanisms of reductive stress disease. Our work will extend from studies that model reductive stress in the genetically amenable fruit fly Drosophila melanogaster, through cultured mouse and human cells, to whole mice, and finally into patients as we work to develop diagnostic tools. Cuttingedge imaging techniques will be developed for monitoring redox couples and toxicities in living cells and tissues. Genetic screens in Drosophila will guide the identification of new genes and determine the effects of potentially therapeutic compounds that prevent reductive stress disease. Validation in mice of interacting genes and pathways will provide us target candidates for pharmacolog

Public health relevance
Currently, 3 million Americans suffer from heart failure and 500,000 new cases are diagnosed annually. An even greater 5 million people have Alzheimer’s in the US. Both conditions are not widely viewed as common protein misfolding diseases, whose mechanism, pathophysiology and therapies remain elusive goals in the genomic era. Added to these are many thousands of patients suffering from a variety of other neurodegenerative diseases that are characterized by misfolding and aggregation of particular proteins. These diseases inflict severe suffering on patients and their families and cost many billions of dollars in treatment every year. The unifying theme for our Pioneer application is the characterization of the molecular determinants and organismal consequences of human disease-causing mutations linked to reductive stress. Our approach combines complementary, horizontally-based model system platforms (i.e., mouse and human cells, flies and mice) with sets of experiments that are integrated vertically from the molecular level up to whole animal physiology and phenotype.